Fatty acid signaling in the pancreatic tumor microenvironment

PROJECT SUMMARY/ABSTRACT
Despite significant recent advances in precision medicine, pancreatic ductal adenocarcinoma (PDAC) remains
near-uniformly lethal. While the most frequent genomic alterations in PDAC are not presently druggable and
conventional therapies are often ineffective in this disease, immune-modulatory therapies hold promise to
meaningfully improve outcomes for PDAC patients. Development of such therapies requires an improved
understanding of the immune evasion mechanisms that characterize the PDAC microenvironment, including
frequent exclusion of antineoplastic T cells and abundance of immune-suppressive myeloid cells. We recently
found that cancer cell-intrinsic glutamic-oxaloacetic transaminase 2 (GOT2) shapes the immune
microenvironment to suppress antitumor immunity. Mechanistically, we found that GOT2 functions beyond its
established role in the malate-aspartate shuttle and promotes the transcriptional activity of nuclear receptor
PPARd, facilitated by direct binding to PPARd ligand arachidonic acid. While GOT2 in PDAC cells is dispensable
for cancer cell proliferation in vivo, GOT2 loss results in T cell-dependent suppression of tumor growth, and
genetic or pharmacologic PPARd activation restores PDAC progression in the GOT2-null context. This cancer
cell-intrinsic GOT2-PPARd axis promotes spatial restriction of both CD4 and CD8 T cells from the tumor
microenvironment, and fosters the immune-suppressive phenotype of tumor-infiltrating myeloid cells. Our results
to date demonstrate a non-canonical function for an established mitochondrial enzyme in transcriptional
regulation of immune evasion, and here we propose to exploit this novel GOT2-PPARd axis to promote a
productive antitumor immune response with the following specific aims. Aim 1: Assess the therapeutic
potential of targeting the GOT2-PPARd axis in established PDAC. We will perform preclinical evaluation of
GOT2/PPARd pathway inhibition together with therapeutic approaches aimed to increase antitumor T cell activity
in diverse mouse models, validate our findings in patient specimens with known clinical outcomes and mutational
status, and assess heterogeneity across the patient population with respect to the association between GOT2
signaling and T cell spatial regulation. Aim 2: Analyze the immune evasion mechanisms driven by cancer
cell-intrinsic GOT2. We will apply in vitro co-culture systems, in vivo assays testing a suite of GOT2 mutants
with varying fatty acid signaling capacity, and unbiased transcriptional analyses to understand the stepwise
mechanisms mediating paracrine regulation of immune evasion. Aim 3: Interrogate fatty acid-mediated gene
regulation by GOT2 and PPARd. We will analyze the genome-wide binding patterns of PPARd and additional
immune-modulatory transcription factors putatively regulated by GOT2, and characterize chromatin states in the
context of fatty acid signaling perturbations that prevent or permit antitumor immune responses. This work will
leverage our recent identification of a novel immune suppression mechanism in PDAC, with the potential to
inform on new therapeutic combinations poised for clinical translation.

Public health relevance
PROJECT NARRATIVE Understanding the mechanisms that enable pancreatic cancer to progress unimpeded by the immune system would inform on the complex biology of this intractable disease and help to identify potential strategies for therapeutic intervention. The studies proposed here will test the novel hypothesis that fatty acid signaling within pancreatic cancer cells controls expression of genes whose products signal to the surrounding microenvironment and suppress immune-mediated tumor growth control. Together, these studies will help us understand the mechanistic basis of growth-permissive tumor-stromal interactions in the pancreatic tumor microenvironment, and may identify novel, druggable targets to help achieve therapeutic benefit in patients.